Developing Safe and Effective GD2-CAR T Cell Therapy for Diffuse Midline Gliomas

PROJECT SUMMARY
Brain tumors are the leading cause of cancer related death in children; among these, diffuse intrinsic pontine
glioma (DIPG) and other histone-3 K27M (H3K27M) mutated diffuse midline gliomas (DMGs) are the most
aggressive and are universally fatal with current standard therapies. Despite several decades of investigational
trials testing dozens of therapeutic approaches, median overall survival for DIPG is 11 months. Chimeric antigen
receptor (CAR)-expressing T-cells have mediated impressive clinical activity in B-cell malignancies, and recent
preclinical and early clinical results suggest benefit in CNS malignancies. We discovered homogenous, high
overexpression of the GD2 ganglioside on H3K27M DMGs and demonstrated impressive antitumor effects in
xenograft models of H3K27M-mutant DIPG following treatment with GD2-CAR T cells (GD2-CART, Mount, Nat
Med 2018). Significant clinical experience with GD2 targeting CAR T cells, available mostly from studies in
neuroblastoma, demonstrate safety and some early signals of antitumor activity. Safe and effective translation
of these findings to children with DMGs would transform the landscape for this universally lethal pediatric brain
tumor. This bench-to-bedside-to-bench project will conduct three aims in parallel leveraging a recently launched
single institution Phase I trial of GD2.BB.z.iCasp9-CAR T cells administered intravenously following a
lymphodepleting preparative regimen in children and young adults with H3K27M DMGs. The first aim focuses
on safety, integrating insights gleaned in our preclinical models into trial design to diminish the risk of tumor
inflammation associated neurotoxicity (TIAN), to establish best practices and to develop improved grading and
treatment algorithms for this novel toxicity. The second aim focuses on efficacy, assessing clinical activity of
GD2-CART in DMG and identifying biomarkers and clinical features associated with response. We further
address the limitations of standard radiographic imaging in these infiltrative tumors using a novel machine
learning aided MRI radiomics approach to quantify textural changes within the tumor and assess whether such
changes correlate with clinical outcome, and we assess whether GD2-CART induced changes in CSF cell free
DNA can provide a rapid quantitative assessment of antitumor response. Our third aim is a discovery aim,
focused on improving understanding of the biology associated with myeloid cell activation following GD2-CART
therapy for DMGs, which we observe in preclinical models and we observed in the first patient treated. Here we
undertake comprehensive single cell profiling of CSF myeloid cells emerging post-GD2-CART in patients
enrolled on the study and in preclinical models, and bedside-to-bench translation using murine models to test
the hypotheses that GD2-CART induced CNS myeloid cell expansion/activation limit the efficacy of GD2-CART,
are modulated by corticosteroid therapy and that this obstacle can be overcome by engineering CD47
overexpression in the GD2-CART.

Public health relevance
PROJECT NARRATIVE: CAR based immunotherapies are now credentialed as potent tools against hematologic malignancies and early signals suggest that these therapeutics may prove beneficial against brain tumors. Building upon impressive results in preclinical models, this project will undertake a Phase I trial of GD2-CAR T cells in H3K27M diffuse midline gliomas, universally lethal tumors of childhood and young adults. The project seeks to ensure the safety of this therapy for patients with brainstem gliomas where the risk of toxicity due to tumor edema is high, will use novel approaches to measure clinical efficacy and seek to define biomarkers or response, and will undertake studies focused on interrogating the biology of myeloid cell activation following CNS directed CAR T cell therapies that has been observed both in preclinical and clinical studies.